Neurobehavioral mechanisms of parent-child extinction learning in adolescent PTSD

Project Summary
The goal of this proposal is to elucidate neurobehavioral mechanisms of parent-child extinction learning in
early adolescent PTSD. Notably, deficits in directly learned fear extinction are implicated in adult PTSD.
However, youth with PTSD live within the family system, which could impact their ability to extinguish trauma
memories. Indeed, abnormal parent-child transmission of fear following trauma is a potent risk factor for youth
PTSD. Furthermore, trauma-focused cognitive behavioral therapy (TF-CBT), the gold-standard treatment for
pediatric PTSD, uses exposure therapy of the child's trauma narrative for both youth and their caregiver. Here,
TF-CBT aims to promote extinction of trauma-related fear both directly in the child and vicariously through
parent modeling. However, no reported studies have examined the cumulative impact of direct and vicarious
fear extinction in pediatric PTSD. Finally, the diagnosis of PTSD in youth continues to rely on DSM syndromal
criteria, creating a great need to establish objective, biologically based diagnoses. This innovative research
program will (1) identify physiological impairments in direct/vicarious fear extinction and their unique
contributions to adolescent PTSD, (2) identify the neural substrates of fear acquisition and direct/vicarious
extinction learning in adolescent PTSD, and (3) use machine learning on biomarkers of fear acquisition and
direct/vicarious extinction to classify trauma exposure and PTSD diagnosis in adolescents.
This interdisciplinary research team will recruit 40 non-traumatized typically developing (TD) youth, 40 trauma-
exposed comparison (TEC) youth without mental illness, and 80 medication-free youth with PTSD, ages 10-14,
along with their primary caregiving parent. Youth and parents will undergo fear acquisition followed by a novel
fear extinction paradigm. Here, youth will undergo two extinction training conditions: 1) direct extinction and 2)
vicarious extinction by observing their parent complete extinction training. Parent/child skin conductance and
corrugator EMG will be measured during all fear protocol phases. Additionally, youth will complete all fear
phases during fMRI to probe neural substrates of fear acquisition, and direct and vicarious extinction. Following
physiological and fMRI analyses, a deep evolutionary machine learning approach will be applied to youth
neurophysiological fear indices to classify trauma and PTSD status. Primary analyses will 1) examine
physiological markers of direct and vicarious extinction in youth and their relative contribution to PTSD, 2)
examine neural abnormalities during direct and vicarious extinction in adolescent PTSD, and 3) determine
whether adding vicarious extinction markers enhances machine learning classification of youth trauma and
PTSD status. This ambitious program of parent-child extinction learning promises to yield the first
comprehensive set of neurophysiological markers of pediatric PTSD that will allow for objective, rational
targeting of treatment in the parent-child dyad to improve outcomes for afflicted youth.

Public health relevance
Project Narrative This project seeks to conduct the first comprehensive, biological study of how parent-child fear and safety learning contribute to adolescent PTSD. This project will establish biomarkers of parent-child safety learning in adolescent PTSD, and test whether machine learning can use these markers to diagnose PTSD in youth. This research would represent a significant advance beyond subjective assessments currently used in clinical settings, paving the way towards biologically-based diagnosis and treatment of youth PTSD within the family context.